Understanding how exocrine-derived signals promote beta cell growth

PROJECT SUMMARY
The pancreas has commonly been considered two distinct organ systems wherein the endocrine compartment
is responsible for hormone secretion and the exocrine compartment is responsible for the secretion of digestive
enzymes. Although distinct, the endocrine and exocrine pancreas are functionally and structurally connected,
working together to maintain metabolic homeostasis. Diseases of the exocrine can impact the endocrine;
however, not all cases of exocrine disease result in endocrine dysfunction. For example, 50 - 80% of
individuals with pancreatitis or exocrine insufficiency do not develop diabetes. This suggests that in certain
instances the loss of exocrine pancreas may support the continued growth and function of the endocrine.
Currently, there remains an incomplete understanding of the molecular pathways and communications that
exist between cells of the endocrine and exocrine pancreas. Published studies and preliminary data from our
lab reveal that hypusine biosynthesis plays a role in exocrine growth and function, which in turn may influence
beta cell growth. Hypusine biosynthesis involves the post-translational modification of eukaryotic translation
initiation factor 5A (eIF5A) by the enzyme deoxyhypusine synthase (DHPS) to form hypusinated eIF5A
(eIF5AHyp), which functions in mRNA translation. Our studies demonstrate that loss of eIF5A in the developing
pancreas causes a reduction in the synthesis of proteins involved in exocrine growth and function as well a
loss of exocrine mass. Interestingly, the reduction in exocrine mass is concomitant with an increase in beta cell
mass. Therefore, I hypothesize that the loss of exocrine mass, rather than altered mRNA translation, at the
stage of exocrine differentiation drives beta cell growth due to the reduced amount of exocrine and exocrine-
derived proteins. To test this hypothesis and determine if it is the loss of exocrine or the loss of eIF5A that
stimulates beta cell expansion, I will perform experiments outline in two specific aims. Experiments in aim 1 will
investigate how the absence of exocrine instructs beta cell growth in the embryonic and adult setting.
Experiments in aim 2 will investigate how alterations in mRNA translation directly impacts exocrine growth and,
resultantly, beta cell mass. In particular, my studies may identify exocrine-derived factors stimulate beta cell
growth. Moreover, this award will provide critical holistic training encompassing five central objectives, which
include: 1) building a strong background in techniques and concepts pertinent to diabetes research; 2) honing
my scientific writing skills communication; 3) practicing my oral scientific communication; 4) enhancing my
skills as a mentor; and 5) professional career development. My training plan also includes direct and
enthusiastic support from my sponsor and co-sponsor, a thesis advisory committee composed of established
NIH-funded investigators, and all of the resources/facilities in the IUPUI Department of Biology and the Center
for Diabetes and Metabolic Diseases at the Indiana University School of Medicine, which will help me progress
in my path to become an independent, diabetes-focused researcher.

Public health relevance
PROJECT NARRATIVE How the exocrine influences the growth and function of the endocrine is an understudied area of research. This application explores the impact of exocrine pancreas insufficiency on beta cell growth as well as the translational mechanisms that may mediate this exocrine-endocrine crosstalk. Data produced from these studies will lead to the identification of exocrine-derived factors that promote beta cell growth, which can be exploited for the development of therapeutics for individuals with diabetes.